Elucidating the role of the Integrated Stress Response pathway in tissue homeostasis

PROJECT ABSTRACT
Elucidating the role of the Integrated Stress Response pathway in tissue homeostasis
Metazoa have evolved stress response pathways to combat internal and external stressors (e.g.,
nutrient deprivation, changes in environmental conditions, toxic insults). The Integrated Stress
Response (ISR) is one such evolutionarily conserved pathway that mediates adaptation to cellular
stress. Since its discovery in yeast, much effort has been dedicated to studying the role of ISR signaling
in mediating the cellular response to exogenous stress. In higher organisms, many specialized cell
types have evolved to rely on the ISR to maintain homeostasis: notable examples of this include
metabolically active cells such as hepatocytes and adipocytes, highly secretory cells such as b-islet
cells of the pancreas, and neurons with high protein turnover such as photoreceptors. Our current
understanding of ISR signaling in maintaining tissue homeostasis largely comes from phenotypic
observations in loss-of-function mutants, yet little is known about the underlying molecular and cell
biology of such regulation. This proposal seeks to gain new insights into the precise molecular and cell
biological mechanisms governed by ISR signaling in maintaining tissue homeostasis. We will use the
Drosophila fat tissue and ovary as a discovery platform, owing to the breadth of genetic and molecular
biology tools available for manipulation of these tissues.
The different branches of ISR signaling culminate in the highly conserved transcription factor,
ATF4. We recently described a role for Drosophila ATF4 in the regulation of oogenesis. Our preliminary
data revealed that while some of the oogenesis defects (e.g., oocyte maturation) arise from
autonomous requirement for Atf4 in the ovary, several others (e.g., yolk protein accumulation, egg
laying) are mediated tissue non-autonomously by Atf4 in the fat tissues surrounding the ovary. Based
on these data, we test a role for ISR signaling as a fat tissue metabolic sensor, which informs peripheral
tissue function non-autonomously. Leveraging our extensive background in molecular and cell biology
techniques with powerful Drosophila genetic tools, we will pursue three projects to establish the role for
ISR signaling 1) in regulating steroid hormone signaling in fat tissues, 2) in fat tissue-mediated
neuromodulation, and 3) in the mRNA translational control in the ovary. Gaining molecular
understanding of the role for the ISR in tissue homeostasis will fundamentally inform our approach to
experimentally and therapeutically improve tissue function. The advancements from this study will also
bear vast pathobiological relevance since ISR dysregulation is associated with an ever-increasing
number of diseases, from diabetes to neurodegeneration and cancer.

Public health relevance
PROJECT NARRATIVE Stress response mechanisms play a dual role in organism health- they are required for tissue homeostasis and also for minimizing damage during toxic conditions. Intimate molecular knowledge of these mechanisms will thus inform clinical approaches to prolong tissue function under pathobiological conditions. Consistent with the mission of the NIGMS, the research described herein aims to gain such mechanistic understanding and will have broadly relevance to many pathologies from neurodegeneration to cancer.